Effect of maternal obesity on breast cancer among offspring: role of the gut microbiota

In Minnesota, American Indian (34.1%) and non-Hispanic Black (33.4%) women are over twice as likely to be
obese during pregnancy than non-Hispanic White women of whom 16.6% are obese during pregnancy. This
high incidence reflects the causes of maternal obesity such as low socioeconomic status, high crime rate, and
excess exposure to air pollution. Maternal obesity has widespread adverse effects on the offspring including
increasing their risk of dying from breast cancer. Maternal obesity also permanently disrupts the mutually
beneficial interaction between the offspring and offspring’s gut microbiota, causing gut dysbiosis. Gut dysbiosis
in the offspring is characterized by a reduction in the gut bacteria that produce fecal short-chain fatty acids
(SCFA). SCFAs play pivotal roles in maintaining healthy immune functions, cellular metabolism, and other critical
functions. These compounds act mostly through their receptors GPR43 and GPR41, which are expressed in
immune cells and multiple other cell types. Here, we will test the central hypothesis that the composition of
commensal gut microbes in the offspring of obese dams is causally responsible for an offspring’s increased
susceptibility to mammary tumorigenesis, an effect that likely also reflects altered immunity. We will test this
causal link by performing fecal microbiota transfers (FMTs). The role of GPR43 and GPR41 in mediating the
impact of maternal obesity on offspring will be tested using CRISPR/Cas9 knockout mice. The potential for
clinical translation of our findings will be established by supplementing obese pregnant dams with a commercially
available probiotic mix of SCFA-producing gut bacteria and dietary fiber that increases SCFA production. Such
a combination has been earlier found to be most effective in reversing loss of critical microbes of healthy gut
microbiota from individuals who have consumed an unhealthy Western diet for multiple generations. We will use
allografted E0771 and Py230 mammary tumor models and MMTV-PyMT mice developing mammary tumors at
about age 3 months. Shotgun metagenome sequencing and mass spectrometry will be applied to study gut
microbiota and their metabolites, respectively. Changes in immune cell infiltration and activity will be measured
in multiple tissues and compared with the expression of GPR43 and GPR41 in immune cells. Our studies could
lead to effective and safe prevention strategies against breast cancer and its growth in the daughters of obese
mothers, and be particularly beneficial for communities suffering from health disparities.

Public health relevance
We will investigate if gut dysbiosis, characterized by significantly reduced fecal levels of short- chain fatty acids (SCFAs) and the expression of SCFA receptors GPR43/Ffar2 and GPR41/Ffar3, are causally linked to increased mammary tumorigenesis in the offspring of obese dams. We also will investigate if supplementing obese pregnant dams with SCFA producing probiotics and fiber will prevent the increase in mammary tumorigenesis in their offspring.